Biometry Web Projects-CCOP and MB-CCOP Management System (CCOPSYS)

Community Clinical Oncology Program (CCOP), Minority-Based CCOP (MB-CCOP), and Research Base Management System (CCOPSYS): CCOPSYS is a web-based system that supports NCI’s Community Clinical Oncology Programs and minority-based CCOPs. A CCOP is a Division of Cancer Prevention (DCP) funded group of hospitals and/or private practices that accrues patients to cancer treatment and prevention/control clinical trials. The major functions of CCOPSYS are to: ¿ Allow CCOP personnel to provide quarterly trial accrual figures to NCI and to allow CCOP personnel to roster physicians to research bases who design, develop, and conduct clinical trials. ¿ Enable NCI personnel to summarize accrual by a variety of parameters, roster CCOP performance sites (where patients are being treated) to research bases, and project/construct CCOP budgets from existing and estimated accrual figures. CCOPSYS is being modified to allow CCOP personnel to request site and person roster updates through a single point of entry and to enable CCOP personnel to upload membership documents for both sites and persons. Roster requests will be handled by through an external credentialing module and updates will be populated to multiple systems including the Regulatory Support System (RSS), Cooperative Group systems, and CTEP applications.